Assessing completeness and accuracy of the EHRs harbored at BigMouth Dental Data Repository-Supplement

Project Summary/Abstract
This proposed application will focus on exploring new methods and strategies to improve the usability of
Electronic Health Record (EHR) data for the purpose of oral health research, dental education and patient
care. The research will assess the data quality dimensions at group-level (faculty vs. student) and at institution
level (across the nine dental school sites). The three quality dimensions will be –completeness, accuracy and
consistency of the EHR data stored in the BigMouth dental data repository for the years 2017-2019. This
project will analyze the completeness by assessing the granular components - demographics, dental history,
behavioral attributes, and health history attributes inputted by the student and faculty providers for missing
data. These granular components will be measured across variables, time, and patient. Patterns of missing
data will be evaluated using multiple imputations. The accuracy of the data will be measured by comparing the
odontogram to the corresponding radiographic image. The consistency that pertains to the constancy of data
within a large dataset will be measured by comparing BigMouth and All of Us attributes that will provide a
benchmark for these demographics and patient characteristics in large data sets and enhance the quality and
confidence in the data repository. All the analysis will be done using the EHR data from the BigMouth dental
data repository that contains clinical data from nine dental schools. This research will facilitate the importance
of using EHR data in oral health research; understand the importance of data validation and reliability, and
improving patient care outcomes within the dental schools that contribute to this repository.

Public health relevance
Project Narrative The proposed research project will analyze the quality of data stored in the BigMouth dental data repository. This data repository is produced by the clinical data deposited by nine dental schools in the U.S. The focus of this application is to analyze three data quality dimensions—accuracy, completeness, and consistency from to increase the reliability and usability of EHR to advance oral health research. High-quality EHR can be a crucial component for patient care delivery, and decision-making in treatment planning, clinical and health disparities research, evidence-based dental education, and several other aspects of patient care delivery and research. It is also an indispensable vehicle for improving the training of future dental providers. This project will evaluate three data quality dimensions—accuracy and completeness, at group-level (faculty-level and student-level) and at the institutional level. Consistency will be measured at the database level, with BigMouth being benchmarked against the All of Us database. The results can improve the usability of the EHR data stored in the BigMouth Dental Data Repository for research, education, and patient care.